Endothelin-1 System Activation and Retinal Microvascular Dysregulation during Early Diabetes

Diabetes mellitus causes microvascular complications in the retina and is a leading cause of blindness in the United
States. Treatments to restore vision are limited. Reduced retinal blood flow occurs in early diabetes, suggesting
that vasomotor dysregulation of retinal arterioles and/or venules leading to ischemia may contribute to later retinal
damage. However, no study has examined both arteriolar and venular vasomotor function together in the retina of
same diabetic subjects. Thus, a gap in knowledge is the limited understanding of mechanisms for retinal
arteriolar/venular vasomotor dysregulation in early diabetes to yield treatment before overt pathology. Excessive
production of vasoconstrictor and inflammatory agent endothelin-1 (ET-1) in the retina occurs in early diabetes,
so in-depth insight into molecular events regulating vasomotor responses to ET-1 in health and disease has
clinical implication. This proposal is based on evidence in type 1 diabetic pigs showing reduced retinal blood flow
at 2-wk diabetes, along with elevated retinal lactate and diminished oscillatory potentials in the electroretinogram,
indicating retinal ischemia and neural abnormality. Also, vitreous ET-1 level and retinal arteriolar endothelin-
converting enzyme-1 (ECE-1) activity were elevated in diabetic pigs. Because ET-1 is derived from ECE-1 and causes
vasoconstriction via Rho kinase (ROCK) signaling, activation of ECE-1/ROCK may lead to retinal vasomotor
dysregulation and flow deficiency in early diabetes. Interestingly, diabetes enhances retinal venular, but not arteriolar,
constriction to ET-1 by activating reverse-mode Na+-Ca2+ exchanger (NCX), possibly involving Na+-H+ exchanger-1
(NHE1) and stress kinases (p38 and JNK). Thus, the objective of this study is to unveil the sequential molecular
pathways for vasomotor dysregulation of retinal arterioles and venules that promote retinal ischemia in early
diabetes. The central hypothesis is that early diabetes activates microvascular ECE-1 leading to enhanced ET-
1 production, which promotes retinal arteriolar constriction via Ca2+-dependent ROCK2/JNK signaling. In early
diabetes, the elevated ET-1 not only elicits retinal venular constriction via Ca2+-dependent ROCK1/JNK axis but
also augments the response by further promoting Ca2+ entry through activation of the p38/NHE1/NCX axis. The
cooperative promotion of arteriolar and venular constrictions to elevated ET-1 contributes to retinal ischemia and
neural abnormality. Two specific aims will be pursued to support the hypothesis: (1) Determine roles of ET-1
system activation and its molecular signaling in promoting retinal arteriolar constriction and consequent retinal
ischemia via Ca2+-dependent ROCK2/JNK axis in early diabetes. (2) Determine roles of ET-1 system activation
and its molecular signaling to augment retinal venular constriction with consequent retinal ischemia via Ca2+-
dependent ROCK1/JNK axis and activated p38/NHE1/NCX signaling pathway in early diabetes. Outcomes will
advance the knowledge of diabetes-induced retinal complications and suggest effective molecular targets for
improving and protecting retinal microvascular perfusion of the retina in early-stage diabetes before development
of retinal structure damage.

Public health relevance
Project Narrative Diabetes mellitus causes progressive functional and structural damage of blood vessels and neurons in the retina of the eye that can lead to vision loss, and is the leading cause of blindness among working-aged adults in the United States. Our studies demonstrate that early diabetes can cause abnormal regulation of the retinal microvessels (arterioles and venules) leading to insufficient supply of oxygen and nutrients to the neural cells for proper function. Because effective therapies are lacking to treat vascular and neural damage during the advanced stage of diabetes, the goal of this proposal is to identify novel destructive proteins in the retinal microvasculature that can be targeted for therapy to improve blood flow and consequently the retinal function in early diabetes before the development of irreversible structural damage to the retina.